Understanding Community Obesity Initiatives and Informing Tailored Community Interventions to Reduce Childhood Obesity

Childhood obesity rates in the United States increased dramatically between the 1980’s and the 2000’s and
remain high in all demographic sub-groups. The rates are particularly high in African American and Hispanic
children. In response to these trends and following the recommendations of leading health authorities, many
U.S. communities have implemented programs and policies aimed at improving children’s diets, increasing
their physical activity levels, and reducing childhood obesity. However, the impact of these efforts has been
limited, and neither research nor professional practice has yet identified the attributes of community programs
and policies that are consistently successful in improving children’s diet, increasing their physical activity, and
decreasing the probability that they will develop overweight or obesity. The overarching goal of the proposed
research is to produce findings that inform public health policies and practices aimed at reducing disparities in
the prevalence of childhood obesity. Specific aims will be to identify attributes of community programs and
policies that are associated with children’s diet, physical activity and weight status within groups of
communities, schools, and families stratified by race/ethnicity and socioeconomic status. These aims will be
addressed by conducting secondary analyses in an existing dataset that includes in-depth observations of a
diverse sample of over 5000 children and assessment of over 9500 community programs and policies to
reduce childhood obesity in 130 U.S. communities. Further, within those communities, extensive data on
school nutrition and physical activity policies, practices and resources are available for 274 elementary and
149 middle schools. A home-based data collection protocol provided anthropometric data as well as detailed
information on children’s diet and physical activity behaviors. Two analytic methods, Classification and
Regression Trees (CART) and Gradient Boosting Machines (GBM), will be employed in examining
relationships between attributes of community programs and policies and children’s diet, physical activity and
weight status. These analytic procedures will be conducted within sub-groups of communities, schools and
families stratified by race/ethnicity and socioeconomic status profiles. The findings of the proposed study will
enable researchers and practitioners to tailor community-based interventions to the characteristics of
demographic sub-groups. This research will be significant because it will inform strategies for preventing
childhood obesity in communities and population sub-groups that are disproportionately affected by the
negative consequences of obesity. The study will be innovative because it will apply state-of-the-art analytical
methods using a dataset that is uniquely large and comprehensive.

Public health relevance
Childhood obesity rates have increased dramatically in recent decades, and remain particularly high in African American and Hispanic children. The proposed study will utilize a unique dataset, which includes data on 5000 children and youth in 130 communities, to identify characteristics of community programs and policies that influence children’s diet, physical activity, and weight status, in communities, schools, and families of different race/ethnicity and socioeconomic groups. The results of this study will provide researchers and practitioners with a better understanding of how to tailor community programs and policies in order to prevent childhood obesity in communities at greatest risk of experiencing the negative effects of obesity.